Brain Healthy Soul Food Diet Intervention Among Older African Americans

PROJECT SUMMARY
AD is the 4th leading cause of death among African Americans and African Americans are two to three times
more likely to develop AD compared to non-Hispanic Caucasians. Given the high prevalence of diabetes and
obesity and the emerging evidence that up to 50% of AD cases are a result of modifiable risk factors,
prevention strategies may play a critical role in reducing AD risk for AAs. Previous research has indicated that
adherence to healthy diets such as the Mediterranean diet, Dietary Approaches to Stop Hypertension (DASH),
and Mediterranean-DASH Intervention for Neurogenerative Delay (MIND) help slow cognitive decline among
adults 65 years and older. However, adherence and acceptability of such diets remain low among African
Americans, due to lack of cultural considerations. Thus, there is a critical need for the development of a
culturally adapt brain healthy diet that is congruent with African American cultural values and food
preferences. Creating a culturally relevant brain healthy diet for African Americans, will enhance both
acceptability and adherence which are essential to lifestyle behavioral changes. The proposed project aligns
well with the NIA Strategic Directions for Research Goal C-3: Develop interventions for treating, preventing, or
mitigating the impact of age-related diseases and condition; by meaningfully incorporating a culturally tailored
approach to an adapted diet intervention to reduce the risk of cardiovascular risk factors related to AD and to
maintain independence among older African Americans. Specifically, Dr. Shaw plans to address the following
specific aims (1) develop an adapted brain healthy soul food diet intervention; (2) pilot test an adapted brain-
healthy soul food diet intervention; (3) explore the effect of the adapted brain-healthy soul food diet intervention
of cognitive function as preliminary data to design a RCT. To achieve these specific aims, Dr. Shaw will work
with a highly skilled mentorship team (Drs. Jeffrey Burns, Debra Sullivan, and Janette Berkley-Patton) and
consultants (Dr. Crystal Glover and Mr. Broderick Crawford) to build four areas of expertise relevant to the
research agenda: (1) ARDR clinical trial design and implementation (2) cultural tailoring of established diets (3)
qualitative design and analysis (4) community-based research design. The K01 award will enhance Dr. Shaw's
capabilities to successfully transition into an independent researcher who has expertise in the development
and evaluation of culturally tailored lifestyle interventions to reduce AD risk among African Americans. Results
of the proposed research will enhance our understanding of how AA culture influences current dietary practice,
adherence, acceptability, and feasibility of a brain-healthy diet for older AA. Results will also positively impact
the development of R01 scale RCT to test the efficacy of an adapted brain-healthy diet intervention among
older AA across a larger geographical area.

Public health relevance
PROJECTIVE NARRATIVE African Americans experience higher rates of Alzheimer's disease (AD) in which half of the cases are a result of risk factors that can be modified by diet. However, limited research has specifically focused on the development of culturally tailored dietary strategies aimed to reduce the risk of AD among older African Americans. This study will (1) design an adapted brain-healthy soul food diet intervention by identifying the cultural context under which a brain-healthy diet is perceived and practiced among African Americans; (2) use a community-based approach to pilot test an adapted brain-healthy soul food diet intervention; (3) explore the effect of adapted brain-healthy soul food diet intervention on cognitive function as preliminary data to design an RCT.